IUDR AS A RADIOSENSITIZER IN UNFAVORABLE NEOPLASMS

Overall, we have continued to accrue considerable numbers of patients on this protocol: (current total 107) the focus this year continues to be obtaining biopsies as delineated in the original protocol for thymidine replacement. The results have been variable, but no toxicity was encountered in biopsy of these patients. We continue to control some of the unresectable sarcomas, many of whom now have received prior chemotherapy, for whom there is no practical option. These have been published in Cancer. A long-term follow-up of the glioblastoma results were published in the Journal of Clinical Oncology. A review article was published in the British Journal of Radiology. Encouraging results have been observed in the subset of patients with anaplastic astrocytomas and presented at the ASTRO meeting. These findings were published in the international Journal of Radiation Oncology. We have started a small pilot study for IUdR in locally advanced head and neck cancers: 12 patients have been treated and we have documented high IUdR uptake and high response rates. This work was published in the Journal of the National Cancer Institute.